Investigating Donor Authorization and Public Perceptions of Normothermic Regional Perfusion to Inform Ethical Organ Donation Practices

PROJECT SUMMARY
Among the most promising efforts to reduce the shortage of organs for transplant is increasing recovery
and donation of organs after circulatory determination of death in hospital settings (cDCD). One of the key
challenges associated with cDCD is mitigating organ damage from warm ischemic time, meaning the duration
of time an organ is without blood circulation. In situ thoraco-abdominal normothermic regional perfusion (TA-
NRP) via extracorporeal membrane oxygenation initiation is a cost-effective method for reducing organ injury
from ischemic time, which also allows for organ function assessment. By re-perfusing organs after circulatory
death, TA-NRP leads to recipient outcomes on par with those from organs transplanted after death by
neurologic criteria. TA-NRP has been used internationally for decades, and its use is increasing rapidly across
the United States.
Prior to initiating TA-NRP, the donor is taken off life-sustaining treatment pursuant to patient wishes, and
the donor’s circulation ceases naturally. After the patient is declared dead, organ recovery surgeons surgically
cut off blood flow to the brain, and then the deceased donor is put on circulatory support to perfuse
transplantable organs prior to procurement. This process significantly improves organ quality, leading to better
outcomes for transplant recipients.
Some are concerned that even though blood flow to the brain is surgically prevented, there might remain
other pathways for blood to reach the brain, for example, via vessels around the spinal column. If there is blood
flow to the brain during TA-NRP, there is concern that the donor might have some ability to experience harm
when their organs are recovered. If true, TA-NRP protocol would need to be modified to ensure total brain
blood flow occlusion prior to reinitiating circulation. If this is not possible, then TA-NRP practice might be
unethical.
This study seeks to ask experts with the greatest knowledge about brain blood flow and its connection to
brain function about their perceptions of TA-NRP. By surveying and interviewing neurointensivists, we can
better understand the gravity of concerns about restoration of blood flow and the possibility of brain function
during TA-NRP, and how different elements of TA-NRP protocols mediate these concerns. Our survey and
interview data could determine the urgency with which we must proceed to research studies of brain blood flow
during TA-NRP, and would strengthen recommendations around how TA-NRP should be standardized. This
information will inform how Organ Procurement Organizations discuss TA-NRP with donor families when
seeking authorization for organ donation.

Public health relevance
Project Narrative Thoraco-abdominal Normothermic Regional Perfusion (TA-NRP) is a cost-effective organ preservation method with the potential to vastly increase the number of high-quality hearts and other organs available for over 100,000 people with end-stage organ failure in the United States waitlisted for transplant. But there is concern TA-NRP might re-establish blood flow to the brain during organ recovery, which if true, could cause harm to the donor and violate the Dead Donor Rule. This project seeks to understand neurointensivist perceptions and concerns regarding TA-NRP, to inform recommendations for how TA-NRP should be performed and explained to donor families.